Local and global epigenome regulation of senescence and aging

Project summary
Chromatin and epigenetic information influences gene expression without changing the underlying genome
and can provide cellular memory through cell division. Epigenetic mechanisms are under intense investigation
for regulation of age-related changes in phenotype, including age-related changes in gene expression and
disease states. Studies in animal models reveal that genetic differences underlie longevity, but that non-
genetic contributions play a major role, such as, famously, calorie restriction. Numerous findings, including
seminal observations from our lab, reveal numerous epigenetic alterations in chromatin as eukaryotes age,
and, importantly, are drivers of aging. A major theme in our work is that the epigenome is maintained by an
active process of chromatin homeostasis—that healthy aging involves efficient epigenome maintenance. This
process is imperfect, hence, in aging chromatin disorganization underlies tissue deterioration and organismal
death. Interventions to enhance epigenome maintenance are prominent in our research both to investigate
function and to advance as future therapeutics.
Here, we explore mechanisms of local and global epigenetic changes in driving senescence and aging-
associated phenotypes. We show (1) acquisition of new strong regulatory enhancers (“super-enhancers”) and
hyper-connected enhancer-promoter “cliques” drive gene expression during senescence; (2) enhancer-to-
promoter conversion within gene introns leads to inappropriate “cryptic” transcriptional initiation within genes;
(3) evidence that metabolic enzymes “moonlight” in the nucleus and intersect with epigenetic pathways. Our
results broadly support the hypothesis that changes in chromatin regulation and prominently loss of chromatin
homeostasis leads to dysregulation of the epigenome and the nucleus, accompanied by cellular and
organismal functional decline. In Aim 1, we will investigate how enhancers are rewired during senescence and
aging with a focus on large enhancer communities or cliques. We will decipher how cliques are formed and
identify major transcription factors that drive their formation. In Aim 2, we will investigate how cryptic
transcription is initiated within genes, and transcription factors and epigenetic enzymes that regulate this
process in senescence and aging. Further, our data suggest a link between cryptic initiation and cliques, to be
investigated in detail. In Aim 3 we focus on a nuclear metabolic enzyme, PHDX, that interacts with the histone
acetyltransferase KAT7 to activate senescence-associated secretory phenotypes. Here we will uncover how
PDHX rewires the epigenome to promote senescence phenotypes and will identify whether disruption of the
PDHX/KAT7 interface can be an intervention for age-related diseases. Overall, our research will reveal
chromatin mechanisms—connecting to metabolic mechanisms—underlying stability of the epigenome in
longevity, with the potential to discover new therapeutic targets to disrupt age-related diseases and to extend
healthy lifespan.

Public health relevance
Project Narrative Epigenetic maintenance is pivotal for tissue homeostasis and phenotypic durability, and dysregulation of chromatin mechanisms can lead to age-associated degeneration. The proposed work will investigate mechanistic details of local chromatin changes in governing the epigenetic landscape associated with cellular senescence and liver aging. Findings from this study will expand knowledge of aging-associated epigenetic changes to identify novel interventions to promote healthy aging.